Biochemical Basis of Stress Resistance of Deinococcus radiodurans

As stated in the 2015 report, this project was scheduled for completion by December, 2015 and we met that planned completion date. During this reporting period, we completed development of a manganese-depleted growth medium and a detailed metabolomic analysis of Deinococcus radiodurans with relatively high and low resistance of gamma-irradiation. These were obtained by harvesting the bacteria at different phases of the growth curve. The analysis did not elucidate a metabolic basis for resistance.